Harnessing Extracellular Vesicles to Overcome Radiation Resistance in Pediatric Diffuse Midline Glioma

PROJECT SUMMARY
Diffuse midline gliomas with H3K27M alteration (DMG-H3K27M) are the leading cause of pediatric
brain tumor-associated deaths. All DMG-H3K27M becomes resistant to radiation, the standard of care, and
most children succumb to their disease within two years of diagnosis. New treatment options are urgently
needed. The applicant's long-term goal is to combine engineering and cancer cell biology to lead a research
group that advances extracellular vesicle (EV)-based drug delivery for central nervous system diseases like
DMG-H3K27M. EVs are potent signaling vehicles in the tumor microenvironment and are understudied in
DMG-H3K27M. The overall objectives are to define how DMG-H3K27M derived EVs contribute to radiation
resistance within a heterogenous tumor and to develop EVs as a delivery vehicle for brain-penetrant
radiosensitizers while equipping the applicant with the skills to become a strong, independent cancer
researcher. Preliminary data show that some subclones within DMG-H3K27M are inherently radiation resistant
and can release EVs readily taken up by radiosensitive cells in a receptor-mediated manner. These EVs
protect the recipient tumor cells from radiation-induced cell death. Therefore, the central hypothesis is that the
cargo of DMG-H3K27M extracellular vesicles, particularly microRNAs, drives radiation resistance within these
tumors and that targeting these factors can sensitize DMG-H3K27M cells to radiotherapy. Additionally, the
selective uptake of EVs by DMG-H3K27M cells suggests that EVs can be exploited as a drug delivery tool. The
rationale is that this research will provide novel insights into mechanisms of radioresistance in DMG-H3K27M
and may result in new approaches to target this cancer. The hypothesis will be tested by pursuing two specific
aims: 1) Determine the mechanism of EV-mediated radioresistance in DMG-H3K27M and 2) Engineer
extracellular vesicles to selectively target brain tumor cells and deliver radiosensitizers. The first aim will be
carried out as part of the dissertation research and will use patient-derived DMG-H3K27M cells, proteomics
approaches, and chemical inhibitors to define the mechanism of EV uptake. miRNA mimics and antagomirs will
also be used to overexpress and silence miRNAs found in EV cargo released from radioresistant cells to
identify miRNAs that confer enhanced radioresistance in DMG-H3K27M. Targets will be validated using
zebrafish xenograft models. The second aim will encompass the post-doctoral research and focus on using
single-cell microfluidic methods to engineer non-tumor extracellular vesicles for specificity towards brain tumor
cells and assessing their capability to cross the blood-brain barrier to deliver radiosensitizers. The research
proposed in this application is significant because it will provide new insights into the role of tumor
heterogeneity in driving therapy resistance. This project will also identify new mechanisms of DMG-H3K27M
radioresistance and develop an innovative strategy for drug delivery to optimize the therapeutic efficacy of
radiosensitizers in the brain, potentially improving treatment outcomes for children with DMG-H3K27M.

Public health relevance
PROJECT NARRATIVE The investigation of Diffuse Midline Glioma-derived extracellular vesicles and their impact on tumor radioresistance is relevant to public health, as it addresses the leading cause of pediatric brain tumor-related deaths and seeks to provide new insights into overcoming treatment resistance. By focusing on the functional effects of extracellular vesicles and their potential as drug-delivery agents, this research is relevant to NCI’s mission of understanding cancer mechanisms and developing innovative treatment strategies.